Training Grant in Diabetes and Endocrinology to Enhance Metabolic Healthspan

ABSTRACT
In the setting of the burgeoning obesity epidemic, metabolic health involving diabetes, diabetes-related risk
factors and diabetes-related complications increasingly burden the US health care system. Yet, even as the
disease burden increases, the number of investigators committed to finding ways to prevent and treat
metabolic diseases has lagged persistently behind. The University of Minnesota (UMN) has held a T32 training
grant since 1977 with demonstrated success. Within the last 10 years (n=13 trainees), 10 (77%) are in
research related fields, 5 (38.4%) are Assistant Professors, and 7 (54%) are associated with NIH grants (either
PI or Co-I). To drive the success of the T32 training program moving forward, we have assembled an
outstanding, complementary leadership team (MPI between Drs Chow and Bernlohr) and sharpened the
current proposal’s focus to leverage the recent flourishing success of UMN investigators in metabolic
healthspan, the preservation of metabolic health. The proposed T32 program will provide advanced training in
state-of-the-art research focused on the mechanisms affecting metabolic healthspan and enhancing metabolic
health. To achieve this goal, we will employ a multifaceted approach inspired by our past history to train four
postdoctoral students (MD, PhD or MD/PhD) per year for up to 2 years per trainee. The training approach
includes the following: #1 Provide trainees with the skill sets necessary to perform multidisciplinary research
regarding metabolic healthspan, #2 Provide high quality mentorship, now involving Senior/Associate Mentors
(mentor dyads) to support trainee and Associate Mentor development, #3 Provide an outstanding environment
fusing research and clinical training for physician and PhD trainees, #4 Provide skill development, including the
experience of writing a F32 or alternative career development grant during the second year, for trainees to
thrive in academic medicine and #5 Establish programs that enhance recruitment and retention of diverse
trainees. The overarching objective of the proposed UMN T32 program is to train physicians and scientists for
research careers focused on enhancing metabolic healthspan while providing a thoughtfully-designed training
environment focused on meeting the unique development needs of postdoctoral fellows as they define their
career and research goals.

Public health relevance
PROJECT NARRATIVE Given the increased burden of diabetes, diabetes-related risk factors and diabetes-associated complications in the US population, advanced research training of physicians and scientists in enhancing metabolic health is increasingly imperative. This training program will provide high quality mentorship, a supportive and nurturing environment, and rigorous preparation for a diverse group of physicians and scientists to develop their research portfolio in enhancing metabolic health.